Computational tools for new pharmaceutical paradigms

PROJECT SUMMARY/ABSTRACT
Advances in molecular simulation models and methods have made it possible in many cases to simulate biological
macromolecules and their environments over time scales of physical relevance with near-quantitative accuracy.
In particular, such approaches are now used directly in the pharmaceutical industry to guide synthesis of new
compounds using computed changes in small molecule binding afﬁnities.
However, despite substantial work by many researchers over decades, the majority of protein-ligand binding phe-
nomena related to human health remain prohibitively expensive to model with sufﬁcient accuracy using current
simulation capabilities. Such therapeutic modalities include targeting protein-protein interfaces, kinases and phos-
phatases inhibitors, and partners of short peptide interaction motifs. One signiﬁcant reason for this difﬁculty is
that these targets favor bigger and more ﬂexible binders, with both larger scale motions and less frequent transi-
tions between metastable states, requiring signiﬁcantly more sampling than is currently computationally feasible.
Additionally, existing force ﬁelds have been developed in a piecemeal fashion, do not generalize over all of rel-
evant chemistry, and the proper trade-offs between increased complexity and computational cost of force ﬁeld
improvements are not clear.
We propose to address these challenges building on our extensive expertise in methods development and simu-
lation software for improved biophysical modeling and drug design. In collaboration with other researchers in the
Open Force Field Initiative, my group will work to build systematically improvable force ﬁelds that achieve high
accuracy and broad coverage of NIH-relevant chemistry, that self-consistently model heterogeneous biomolecular
systems, and that can be broadly applied across a range of high-performance software packages. In particular, we
will use new sources of thermophysical data to optimize and validate behavior in complex chemical environments
and will develop statistical approaches to better gauge the utility of increasing force ﬁeld complexity.
In addition, we will develop novel, well-validated molecular simulation sampling methodologies that can capture
the full conﬁgurational ensembles needed to accurately compute binding free energies of large, ﬂexible ligands.
Such algorithms will be designed to support new and anticipated computing architectures such as heterogeneous
clusters and cloud computing via asynchronous approaches, and will augment molecular dynamics with recent
developments in machine learning structural prediction.
This research is signiﬁcant and transformative as the computational concepts and technology developed via this
research will enable accurate prediction of larger, ﬂexible ligands from across all of bioorganic chemistry. The
effort has the potential to assist drug developers break away from existing design paradigms of relatively small,
rigid molecules bound to relatively rigid well-deﬁned binding sites, accessing new targets and mechanisms of
action and as well as therapeutics targeting them.

Public health relevance
PROJECT NARRATIVE This project is designed to improve the power of computer simulations to help develop better medicines, by both improving the quality of computer models used for these simulations, and improving the efﬁciency of the simulations in evaluating new therapeutics. Such improved computational tools have the potential to change the existing paradigms researchers use to ﬁnd new drugs by making it possible to investigate different types of molecular structures than were previously considered.